A novel target in aged fracture healing

ABSTRACT
Bone fractures occur in 50% of the population causing significant morbidity and mortality and costing more than
$20 billion annually. Advanced age diminishes bone repair capacity and is associated with increased surgical
intervention at the time of the injury and subsequently with the need for revisions. The development of therapies
aimed at enhancing bone repair would significantly reduce the burden on the geriatric population. We recently
identified Apolipoprotein E (ApoE) to be an age-associated inhibitor of fracture repair. ApoE is a circulatory
protein and increases in abundance with age in mice and in humans. In our published work, circulating ApoE
inhibited osteoblast differentiation and activity decreasing the amount of bone deposited within the fracture
callus. The liver produces >90% of the ApoE found in circulation, as such, we delivered siRNA against ApoE
using an AAV targeting hepatocytes in aged mice. Circulating levels of ApoE were dramatically decreased and
subsequent aged bone healing was greatly improved. This finding serves as a ‘proof of concept’ that ApoE is a
viable target to improve aged fracture repair. Within this proposal we will build on these findings identifying
interventions that can be translated to clinic to improve aged bone healing. In Aim 1 we will determine whether
neutralizing circulating ApoE improves aged fracture healing. We have developed an ApoE-neutralizing antibody.
A small cohort of aged male mice underwent fracture injury and were later treated with this antibody IP. Versus
IgG-treated mice, the calluses of anti-ApoE treated mice contained higher amounts of bone tissue. In this aim
we will identify the optimal regimen and dose of antibody to use and determine how this treatment changes the
stages of fracture repair. Furthermore, we have identified ApoE-based inhibition to propagate through
osteoblastic muscle-specific kinase (MuSK), a cell-surface tyrosine kinase receptor whose osteogenic
expression and function has yet to be reported in the literature. In Aim 2 we will we will use MuSK floxed mice
crossed with inducible Cre-recombinase mice to identify the role of osteogenic progenitor and osteoblastic MuSK
in bone repair. In Aim 3 we will identify the mechanism by which ApoE decreases osteoblast differentiation.
Using in vitro cell culture techniques, we have identified the Yap/Taz pathway to be modulated with ApoE
treatment. An osteoblastic cell-surface receptor for this pathway has yet to be identified. We have determined
MuSK to potentially serve as such a receptor. Using transgenic mouse models, we will determine functionality
of MuSK in osteoblast biology and investigate the role of MuSK in ApoE-based osteoblast inhibition/signal
transduction.

Public health relevance
PROJECT NARRATIVE – PUBLIC HEALTH STATEMENT Advanced age diminishes bone repair capacity and is associated with increased surgical intervention at the time of the injury and subsequently due to the need for revisional surgery. Apolipoprotein E (ApoE) is a circulatory protein which we show to increase in abundance with age and to have deleterious effects in bone fracture healing. Here we propose to investigate the efficacy of using neutralizing antibodies temporally neutralize circulating ApoE to improve aged fracture healing and to identify the mechanism by which ApoE is able to inhibit bone repair and investigate the function of a newly identified osteoblastic cell-surface receptor, muscle-specific kinase (MuSK).